Host tRNA-derived small RNAs (tsRNAs) mediate interactions between host and oral microbes

Host mucosal surfaces are highly specialized and possess a complex array of innate and adaptive immunity.
They provide the first line of protection against infectious agents by initiating protective responses to potential
pathogens. Furthermore, the symbiotic relationship of the hundreds of microbial species with the host requires
a fine-tuned response at the mucosal surface that prevents overgrowth of opportunistic pathogens, but sparing
beneficial microbes. While small RNAs (sRNAs) have been regarded as a class of intracellular regulatory
elements, emerging studies in plant-pathogen and host-gut microbiome interactions uncover that hosts can
exploit sRNAs, such as transfer RNA (tRNA)-derived sRNAs (termed “tsRNAs”), via encapsulation in
exosomes, as a new mode of bacterial gene modulation or defense mechanism. Yet, it remains to be
elucidated whether such sRNA-mediated inter-kingdom gene modulation or defense mechanism exist in the
context of host-oral microbiome interaction. To address this knowledge gap, the present R01 application will
focus on host-derived, exosome-borne, salivary tsRNAs, of which the biological functions have remained
largely elusive to date. Speficically, we recently demonstrated that human Normal Oral Keratinocyte-
Spontaneously Immortalized (NOKSI) cells released two exosome-borne tsRNAs, tsRNA-000794 and tsRNA-
020498, when challenged with Fusobacterium nucleatum (Fn), a key oral commensal and opportunistic
periodontal pathogen. Importantly, these two tsRNAs can be readily detected from saliva in healthy human
subjects. Intriguingly, both tsRNAs exhibit highly selective, Fn-targeting antimicrobial activity—directly adding
synthetic mimics of these two tsRNAs, but not scramble RNA, to bacterial culture inhibits the growth of Fn, but
not that of Porphyromonas ginigivalis (Pg), a gram-negative periodontal pathogen or Streptococcus mitis (Sm),
a health-associated oral bacterium. In preliminary work, we further took a multi-facet approach to identify a
putative RNA-specific membrane transporter as well as candidate intracellular bacterial protein targets of Fn-
targeting tsRNAs. Building on our comprehensive preliminary data, the goal of this application is two-fold: (Part
I) achieve mechanistic understanding of the cross-kingdom trafficking of host-derived Fn-targeting tsRNAs and
their modulating effect on Fn growth during NOKSI-Fn interaction, through exosome tracking and in-depth
dissection of the tsRNAs transporter and intracellular targets in Fn; (Part II) expand our work to profile and
compare salivary tsRNAs between healthy and periodontitis subjects, with a focus on demonstrating the broad
implication of host-generated tsRNAs as a conserved mechanism to achieve host-microbial homeostasis. The
realization of this application will not only address a fundamental question by defining tsRNAs as a new class
of host defense molecules in maintaining host-microbiome homeostasis via targeted microbial modulation, but
also will pave the way for a new therapeutic strategy against oral diseases, considering the already successful
trajectory of nucleic acid therapeutics in recent years.

Public health relevance
Projective Narrative The interaction between human and its associated bacteria plays a crucial role in determining human’s heath and disease. Our research is focused on studying how human epithelial cells-produced small RNAs can be transported to oral bacteria and affect their behavior. The knowledge we gain through this study will allow us to better understand the interaction between bacteria and oral mucosa and its impact on human oral health.